Inform Shared Decision-making with Advanced Bayesian Causal Inference to Improve Quality of Pediatric Rheumatology Care

PROJECT SUMMARY/ABSTRACT
When faced with treating a child with Juvenile Idiopathic Arthritis (JIA), a heterogeneous chronic condition with
no known etiology or cure, there is no one-size fits all solution. Clinicians rely on their past experiences and
learnings from peers and the scientific community to make the best decision for JIA patients. Yet despite
multiple FDA approved treatments, only 40 percent of patients with a polyarticular form of JIA achieve a state
of controlled disease, it is hard to treat. While clinical expertise is invaluable, relying on clinician experience
alone at point of care (POC) when treating an uncommon (1 in 1000 children) and disabling disease with
heterogeneous presentation and variable treatment response may result in missing a critical window of
opportunity for early remission and suboptimal outcome. Imagine the power of a digital health technology
(DHT) that uses real world data to inform effectiveness of different treatment strategies for every child. By
learning collectively from past experiences of a network of providers and patients that leverage a shared
clinical data registry, the DHT synthesizes, and updates knowledge centered for the patient at the POC, while
considering the values and preferences of patients for shared decision-making (SDM). Currently, there is no
such DHT available to deliver the patient-centered comparative effectiveness evidence at the POC.
This study aims to close such a gap with novel user-centered design to adapt for use at POC an
existing researcher facing application package based on advanced Bayesian causal learning methods applied
to real world electronic health record (EHR) data. This DHT, called PCATS.JIA (Patient centered adaptive
treatment strategies for JIA care) will be implemented within the setting of a 23-center learning health network.
In R21 phase, the study aims to: 1) bring the PCATS platform to the POC by developing a PCATS.JIA DHT
that is EHR system agnostic; 2) co-design a graphic user interface for PCATS.JIA as a patient-centered SDM
tool together with key stakeholders (patients, parents, and clinicians); and 3) pilot test PCATS.JIA as a SDM
tool at POC in a single rheumatology practice. In R33 phase, we will refine, test, and evaluate the PCATS.JIA
in three pediatric rheumatology clinics by 1) using quality improvement science and implementation science
principles to implement PCATS.JIA into the clinic workflow with high reliability; and 2) demonstrating that use
of PCATS will result in improved health care service as reflected in more patient-centered care, improved
health outcomes, and health equity.
The study promises to deliver a novel patient centered DHT that is robust, flexible and improves quality
and equity of care and treatment outcomes as tested within the practice of pediatric rheumatology. Being EHR
system agonistic, it is scalable to different clinical centers. This DHT has the potential to be generalizable to
broader disease conditions and patient populations.

Public health relevance
PROJECT NARRATIVE We propose to deliver PCATS.JIA, a patient-centered shared decision-making tool for use at point of care to improve quality and outcomes of clinical care for children with JIA. The tool will be co-designed with its end- users (patients, clinicians), along with experts in user-centered design, data scientists, and health services and outcomes researchers. We will design and test implementation within the setting of a 23-center Pediatric Rheumatology Care and Outcomes Improvement Network (PR-COIN), leveraging our existing validated computational tool based on an advanced Bayesian nonparametric causal learning algorithm.